Understanding allostery from the perspective of protein dynamics and energy flows

Project Summary/Abstract
Allostery is a fundamental aspect of protein function intrinsic to all proteins. It has important implications in
enzyme catalysis, signal transduction, drug design and protein engineering. Understanding the mechanism
of allostery is of fundamental importance. A rigorous understanding of its mechanism is of fundamental
importance. The essence of allostery is that the binding of an effector to an allosteric site distal from the
active site changes protein function (e.g. an increase in substrate affinity) at the active site. Two fundamental
questions are central. 1) What is the change to the active site, induced by effector binding, that leads to the
increased substrate affinity? This question concerns the nature of the allosteric signal. 2) How is the change
at the allosteric site, introduced by effector binding, communicated to the active site? This question concerns
the allosteric pathway. We propose a new approach to address both questions within a single unified
framework: allosteric signal is a change in functional dynamics induced by effector-binding and allosteric
pathway is the transition pathway of functional dynamics. The energy flow theory we developed provides us
a rigorous approach to identify the pathway and mechanism of functional dynamics, hence the pathway and
mechanism of allostery.
We propose to apply the energy flow method to understand allostery in two representative systems. Aim
1: Identify the allosteric pathway in PDZ domain and elucidate its allosteric mechanism. PDZ domains
are a prototype of “dynamic allostery” and attracted intensive attention. Allosteric residues identified by
existing methods, however, cannot be identified with signal transduction of PDZ domain on a rigorous ground.
Energy flow analysis on ligand-binding and energy relaxation in PDZ domain will enable us to rigorously
determine its pathway for allostery and signal transduction. Aim 2: Identify the allosteric pathway
responsible for non-active-site drug-resistant mutations in HIV-1 protease (HIV-PR) and elucidate the
allosteric mechanism. Our Preliminary Results identified these residues as prominent players in the flap-
opening dynamics, suggesting that their drug resistance is achieved via allostery.

Public health relevance
Project Narrative We will extend the energy flow methodological framework to the analysis of protein allostery. We will apply this method to two representative systems of allostery: PDZ domain signal transduction and drug-resistant non-active-site mutations in HIV-1 protease. We will identify their allosteric pathways and elucidate the physical principles behind the observed behaviors.